High Throughput Digital Droplet ELISA for Ultrasensitive Multiplexed Diagnostics

Abstract:
Digital assays — in which ultra-sensitive molecular measurements are made by performing
millions of parallel experiments in picoliter droplets — have generated much recent enthusiasm
due to their single molecule resolution of RNA, DNA, and proteins, and their robustness to
reaction conditions. These assays have enormous untapped potential for point of care disease
diagnostics, but are currently mainly confined to laboratory settings due to the cumbersome
instrumentation necessary to generate, control, and measure tens of millions of independent
droplets. To overcome this challenge, we propose a hybrid microelectronic / microfluidic chip to
`unlock' droplet-based assays for clinical use. Our microdroplet megascale detector (µMD) can
generate and detect the fluorescence of millions of droplets per second (1000× faster than
existing digital approaches), while achieving a 1000x greater sensitivity than conventional
ELISA, using only a conventional cell phone camera. The key innovation of our approach is
borrowed from the telecommunications industry, wherein we modulate the excitation light with a
pseudorandom sequence that enables individual droplets to be resolved that would otherwise
overlap due to the limited frame rate of digital cameras. To demonstrate the power of our
approach, we focus our attention on the diagnosis of pancreatic cancer.

Public health relevance
Project Narrative: Droplet-based assays, in which microscale emulsions are used as isolated compartments to run many independent chemical reactions, have demonstrated enormous utility in recent years as a platform for the ultrasensitive detection of small molecules, proteins, and nucleic acids. These assays have enormous untapped potential for point of care disease diagnostics, but are currently mainly confined to laboratory settings due to the cumbersome instrumentation necessary to generate, control, and measure tens of millions of independent droplets. To overcome this challenge, we propose a hybrid microelectronic / microfluidic chip to `unlock' droplet-based assays for clinical use. Our microdroplet megascale detector (µMD) can generate and detect the fluorescence of millions of droplets per second (1000× faster than existing digital approaches), while achieving a 1000x greater sensitivity than conventional ELISA, using only a conventional cell phone camera.